Evidence-based intervention enhancements to reduce language delays and disorders among children of parents with substance use disorders

7. Project Summary/Abstract
Children of parents with substance use disorders (SUD) are at greater risk for early language delays (LD) and
subsequent developmental language disorder (DLD). Health disparities in DLD happen because families
impacted by SUD are not able to access interventions to prevent and address DLD. To our knowledge, there
are no national efforts focused on addressing disparities in LD among children of parents with SUD, despite a
clear indicated need. Substance use disorder service providers are uniquely positioned to provide group-based
intervention to families by offering opportunities to support access to early intervention, which is currently
inadequate. Implementing group-based services in these existing settings is resource efficient, builds on
trusted relationships with service providers and, as a result, improves the likelihood of earlier engagement with
services for children to support early intervention efforts. Nesting services within group-based settings in
partnership with culturally-responsive service providers reflects the intersections of SUD, rurality, and language
minoritization. Although group-based PI-NCI improve language outcomes for children, it is unknown whether
individual parent support modalities (e.g., parent coaching and individualized lessons) may confer additional
effectiveness over group intervention alone. To our knowledge, this is the first project to evaluate PI-NCI to
prevent and address LD for children of parents with SUD. The goal of our proposed work is to identify which
intervention modalities work best, for whom, and how each could be practically implemented to promote
adoption, sustainability, and dissemination. We will collaborate with a community impact board to accomplish
the following specific aims: Aim 1: Evaluate the comparative effectiveness and implementation outcomes of
different PI-NCI modalities for improving parent responsivity and child communication and language outcomes
using a factorial experiment (N = 244 parents with SUD of children aged 18-42 months). All parents will receive
a foundational group-based intervention and randomization to 1 of 4 modality conditions such that the parent
coaching and individualized lesson plan modalities are either “off” or “on.” We will use Proctor’s taxonomy of
implementation outcomes to characterize implementation and the likelihood of adoption to support the
translation of research to practice. Aim 2: Identify PI-NCI mediators and moderators of the effectiveness of PI-
NCI among sub-populations of parents with SUD and their children including parent knowledge and self-
efficacy, parent functional impairment, parent psychopathology, and child prenatal exposure. Our work has high
potential to transform the clinical landscape of early intervention for children of parents with SUD by identifying
PI-NCI modalities to decrease the prevalence and severity of LD among children of parents with SUD.

Public health relevance
8. Project Narrative Children of parents with substance use disorders are three times more likely to have a language delay compared to their peers, representing a clear health disparity. Parent-implemented naturalistic communication interventions (PI-NCI) can be used to prevent and intervene on toddler language delays to prevent later developmental language disorders, however, it is unknown whether and to what degree resource-intensive individualized parent supports offer additional benefits over foundational group-based parent education. The study evaluates the comparative effectiveness of individualized supports to augment group-based interventions and the implementation of these PI-NCI modalities to support the widespread adoption and implementation of evidence-based interventions to intervene on the clear inequities in language delays among children of parents with substance use disorders with specific attention to intersectionality.